BIRTH CERTIFICATE LINKAGE TO GROWTH AND HEALTH MEASURES USING NHANESIII

The third National Health and Nutrition Examination Survey (NHANESIII) has collected descriptive data, physical measures, and biomedical samples on a representative U.S. sample of children at ages two months through six years with oversampling for blacks and Mexican Americans. We propose to link the extensive data from NHANESIII to the child's birth certificate to use the prenatal and birth information. Results of the linkage will support research efforts to do the following: 1) To determine if low birth weight or premature children have subsequent poor health as measured by biomedical markers in a representative national sample of children through age six; 2) to assess the effects of ethnic/racial and socioeconomic factors on these outcomes; 3) to develop normative growth and other biomedical scales for a U.S. representative population, and black and Mexican-American children, according to a risk profile at birth; and 4) to develop comparisons between maternal and proxy reports of children's risk factors at birth and actual measurements for use in other studies.